Task A85 Mouse and Guinea Pig Models for Herpesviruses

This contract provides for the development and standardization of small animal models for infectious diseases, and may include efficacy testing of candidate products.